Training Core [Parent Title: NOVEL THERAPEUTICS FOR FSHD]

PROJECT SUMMARY
Facioscapulohumeral muscular dystrophy (FSHD) causes lifelong severe disability and is one of the most
prevalent muscular dystrophies, afflicting both children and adults. While major advances in genetics have
strongly implicated the inappropriate expression of a powerful transcription factor, DUX4, and its target genes
in the degeneration of muscle fibers in FSHD, no protective pharmacologic treatments yet exist for this
disease. The University of Massachusetts School of Medicine (UMMS) Wellstone Muscular Dystrophy
Cooperative Research Center is a network of collaborative investigators whose research and training programs
focus on developing novel and effective therapeutics for FSHD. The long-term objectives are to meet this need
through three highly synergistic projects directed toward drug discovery and optimization, supported by our
Cores, collaborators and advisors. Specific Center goals are: 1) identifying FSHD disease modifiers through
expanded genomic investigations of a large Utah FSHD kindred in Project 1 to discern native gene variants
and regulatory pathways that influence the FSHD clinical phenotype; 2) discovering modulators of DUX4
toxicity in Project 2 using the novel Wellstone FSHD cell and animal models and CRISPR-based inhibition
approaches to identify gene and regulatory pathway therapeutic targets; 3) optimizing our lead DUX4 RNA
therapeutics and DUX4 signaling compounds in Project 3, in collaboration with industry; 4) partnering with
FSHD and patient advocacy groups to support and participate in FSHD research and clinical trials; 5)
expanding collaborations with industry partners who have tools and experience to develop FSHD therapeutics;
and 6) training the next generation of clinician-scientists and translational researchers, who will be the driving
force of our Wellstone therapeutic development program. Three Center Cores will support the research and
training activities of this Wellstone Center and also the greater FSHD research and patient communities. These
include an Administrative Core to facilitate communication between our investigators at all sites and to connect
investigators with patient advocacy groups, particularly the FSH Society, so that we may continue to engage
and provide education to individuals with FSHD and their families. The Education and Training Core will
continue to oversee the research and clinical training of students and fellows. The Resources Core will expand
a unique repository of FSHD biomaterials, including DNA, muscle tissues, myogenic primary cells and muscle
cell lines derived from biopsies, and iPSC cells derived from patient fibroblasts to support Wellstone and
greater FSHD community research. These materials are available to academic and industry groups and have
increasingly been used as FSHD models for biomarker and preclinical therapeutic studies. The Resources
Core will utilize novel inducible DUX4 mouse and zebrafish models and a xenograft model that will support our
proposed preclinical projects and also will share these models with other FSHD research groups to accelerate
FSHD therapeutic development.

Public health relevance
PROJECT NARRATIVE The University of Massachusetts School of Medicine (UMMS) Wellstone Muscular Dystrophy Cooperative Research Center is a distributed, multi-institutional Center with an exceptional team of collaborative investigators and trainees with multidisciplinary clinical and basic research expertise, whose research and training is focused exclusively on Facioscapulohumeral Muscular Dystrophy (FSHD). Center researchers and their academic and industry partners will utilize the Center's unique FSHD patient-derived muscle cell and animal model resources and state-of-the-art genomic, molecular genetic and cell biological technologies to identify novel druggable FSHD disease targets and validate already promising therapeutics. The intent of our Center is to initiate IND enabling studies for several compounds over the next five years.